Precision Neuropathology Core

Abstract - Precision Neuropathology Core
The Precision Neuropathology (NP) Core has been a valuable and frequently utilized resource for UW ADRC
in support of its vision of characterizing and understanding heterogeneity of Alzheimer's disease and related
dementias (ADRD). The NP Core has fostered development of innovative approaches to assess
neuropathology of ADRD, which are essential to more precisely measure neuropathologic change. We build on
this tradition of innovation in this proposal by applying novel, highly quantitative multiplexed immunoassays
developed in the NP Core to measure neuropathology that, combined with better methods of collecting and
storing tissue for state-of-the-art applications including single cell molecular profiling, expanded pathological
sampling informed by structural and functional imaging, ex vivo MRI-guided pathologic sampling in every brain,
and 3D image reconstruction, and quantitative analysis in both gross and microscopic samples, enable us to
deeply characterize the structural substrate for ADRD heterogeneity. We combine this comprehensive analysis
of human brains with a cell types and stem cell component composed of experts in their respective fields who
are committed to providing support for ADRD-related mechanistic studies, all while supporting every core of
the ADRC and local and national research. Thus, our Aims reflect our commitment to integrate traditional
diagnostic excellence and extensive tissue and data sharing with radiographically informed extensive sampling
and a battery of highly quantitative, molecularly specific tissue and in silico approaches to precisely measure
ADRD neuropathology. Our specific aims are to (i) build a highly accessible repository of brain tissue and fluid,
(ii) provide diagnostic expertise according to the latest guidelines, (iii) develop innovative approaches, (iv)
provide cell types and stem cell support for ADRD research, and (v) promote durable ADRD research through
support of ADRC Cores, development projects, and local and national research. All of our research activities
are focused on enhancing the research value of tissue and body fluid donations from cognitively healthy
individuals and those along the ADRD spectrum while ensuring proper safeguards.